Ecological Cognitive Monitoring through AI-Enhanced Personal Photo Activities

PROJECT SUMMARY
Almost 7 million Americans have dementia, yet doctors can only detect memory problems after significant
decline has occurred, missing the chance for early treatment when it's most effective. A further 30 million or
more people potentially having early-stage disease symptoms, and this crisis affects not just patients but also
over 11 million family caregivers. Momento is a smartphone app that helps solve this problem by turning
everyday photo activities into a way to track brain health. The app lets older adults enjoy personalized games
created from their own pictures, while its technology quietly monitors their interactions to detect early signs of
memory changes. What makes Momento unique is that it transforms regular photo activities that people
already enjoy into sensitive measures of brain health, while avoiding the anxiety and cultural biases of
traditional tests. Unlike clinical assessments that feel stressful and are only done occasionally, Momento
gathers rich information naturally through daily engagement with cherished memories, adapting its activities to
each user's interests and abilities. In Phase I, we will: (1) test how well 200 older adults like and use the app,
ensuring they enjoy it enough for regular use, and (2) verify our system can accurately assess brain health by
comparing results with gold standard memory screening tests in 40 participants. In Phase II, we'll expand to
2,000 participants to improve our system across different populations and prepare for FDA approval as a
medical device. We'll also develop personalized reports that help both users and healthcare providers track
changes over time, creating a new standard for continuous brain health monitoring. The business opportunity
is significant - we can serve 300,000 doctors who do memory testing (with Medicare covering $242 per
assessment) and contribute to the $3 billion digital health testing and therapy market for older adults. By
making brain health monitoring part of an enjoyable daily activity, Momento will help doctors catch problems
sooner while advancing our scientific understanding of how memory problems develop.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELAVANCE In this project, Dabble Health will develop Momento, a smartphone app that turns personal family photos into fun memory games and story-sharing activities for older adults. While users enjoy using these personal photos in ways regular photo apps don't offer, the app quietly watches how they play and interact, giving both users and their doctors an easy way to track brain health over time. Unlike current memory tests that only spot problems after they become serious, Momento helps people see and understand their own brain health during everyday use, allowing them and their doctors to take action sooner to maintain their well-being.